MT2007-19R: WCC #53 ALLOGENEIC NATURAL KILLER CELLS IN PATIENTS WITH RECURRENT O

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The purpose of this study is to determine whether IL-2 activated donor natural killer cells combined with fludarabine and cyclophosphamide is a possible treatment for ovarian cancer.